Applying National Standards to Evaluate Cancer Survivorship Care Quality: A Mixed Methods Study

Project Summary:
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as "NOT-CA-
24-041". In this administrative supplement to the parent grant, we apply the National Standards for
Survivorship Care, recently published during the spring of 2024, to evaluate the quality and utilization of the
Buffet Cancer Center (BCC) Survivorship Program. Our evaluation will focus on organizational policies
and processes for delivering survivorship care across our catchment area. This project extends the
parent Cancer Center Support Grant for BCC, which promotes innovative translational cancer research,
excellence in cancer education and training, and outstanding patient-centered cancer care, aiming to reduce
the burden of cancer and cancer health disparities across Nebraska and beyond. Effective survivorship care
requires a patient-centered approach and coordination across medical specialties to ensure quality care.
Findings from this project will inform organizational policies related to survivorship care delivery and broader
cancer care policies, especially those addressing patients' physical and social health needs. The proposed
project will examine the extent to which existing survivorship programs align with the National Standards of
Cancer Survivorship Care and the factors influencing their accessibility and utilization that remain
understudied. Our central hypothesis is that utilization and accessibility of survivorship will vary by cancer type
and patient sociodemographic factors. Understanding these aspects is essential for advancing survivorship
care and promoting the long-term well-being of cancer survivors. The proposed project aims to fill this gap by
evaluating the BCC Survivorship Program using the National Standards for Cancer Survivorship Care1 as a
guiding framework.
Aim 1: Evaluate accessibility and utilization of the survivorship program via electronic health records.
This includes assessing the number of internally referred patients, self-referred patients, visit frequency, and
the number lost to follow-up.
Aim 2: Assess the alignment of the BCC Survivorship Program with the National Standards and referral
pathways for survivorship care. This includes examining the organizational and systemic factors influencing
the delivery of survivorship care, such as institutional policies, resources, and interprofessional collaboration,
using the National Standards for Survivorship Care as a guiding framework.
Aim 3: Identify barriers and facilitators to accessing survivorship care via patient and provider
interviews.
This study will provide critical insights into the effectiveness of the BCC Survivorship Program and offer
practical guidance for aligning survivorship care with national standards to improve outcomes for cancer
survivors.

Public health relevance
Project Narrative: The proposed project examines the extent to which the Buffet Cancer Center Survivorship Program aligns with recently developed National Standards for Survivorship Care by evaluating the organizational policies and processes for delivering survivorship care. Document reviews and interviews will be conducted to assess the alignment of current policies and procedures with the National Standards, as well as EHR analyses to determine survivorship program utilization and examine referral rates and the number of survivors lost to follow-up across cancer types. Using the National Standards for Survivorship Care as a guiding framework, this study seeks to inform policy, practice, and future research efforts aimed at improving the long- term care and outcomes of cancer survivors in the United States.